Optimizing a Weight Neutral Intervention to Improve Health Among Adults of Higher Body Weight: A MOST Preparation Phase Study

Project Summary
Obesity remains a major public health concern and is a leading contributor to cardiometabolic disease. Frontline
treatments aim to directly facilitate weight loss, but outcomes are variable and difficult to sustain. Weight neutral
approaches are gaining scientific, clinical, and public attention as an alternative pathway to reducing
cardiometabolic risk for individuals of higher body weight. These programs support improved quality of dietary
intake and engagement with physical activity without encouraging weight loss, and target novel ‘weight neutral’
mechanisms to support adherence over time (e.g., eating in response to hunger/satiety cues, disengaging from
rigid rules about food, increased body appreciation, combating weight-related stigma, and promoting physical
activity for enjoyment.) Despite growing interest, efficacy for weight neutral interventions on cardiometabolic
health, along with the generalizability, scalability, and sustainability of treatment effects is not established.
Additionally, there is significant variability in how the weight neutral programs are designed (i.e., which weight
neutral mechanisms are targeted and how), leaving it unclear which weight neutral mechanisms meaningfully
contribute to treatment effects. The goal of this R03 is to use the Multiphase Optimization Strategy (MOST) to
build a clearly defined weight neutral intervention that effectively targets the weight neutral mechanisms that are
central to this therapeutic approach. Candidate weight neutral components will include the following existing,
evidence-based interventions with demonstrated effects on weight neutral mechanisms; (1) mindfulness-based
eating awareness training (mechanisms: to increase eating in response to hunger/satiety cues and reduce rigid
dietary restraint), (2) body acceptance program (mechanisms: to improve body appreciation and reduce
internalized weight-related bias), and (3) a tailored intervention to promote enjoyment of physical activity
(mechanism: enjoyment of physical activity). Weight neutral components will complement a Core intervention of
standardized education on healthy diet (emphasizing the Mediterranean diet) and Physical Activity Guidelines
for Americans (i.e., aerobic activity, muscle strengthening and sedentary behavior). Before every potential
combination of Core + Candidate weight neutral components can be tested in a fully powered factorial
experiment, we will conduct necessary pilot testing in this Preparation phase study to ensure we can recruit our
target sample and deliver the novel combinations of weight neutral components as intended. To make strategic
use of resources, a fractional factorial design will be deployed. The Core intervention and conditions with 2+
weight neutral candidate components will be pilot tested. Small groups of racially/ethnically diverse adults with
BMI 25-40kg/m2 (n=50) will be recruited and randomly assigned to one of the five treatment combinations. This
project will leverage the expertise the PI has developed through completion of her NIDDK-funded K23 and
enhance her capacity to transition to independence by launching a related but distinct line of research
investigating the health benefits of weight neutral lifestyle interventions for individuals of higher body weight.

Public health relevance
Project Narrative Traditional approaches to obesity treatment focus on weight loss, but the results are variable and difficult to sustain. Weight neutral interventions hold promise to diversify treatment options by promoting healthy diet and regular physical activity without weight loss; they often include novel components to target barriers that are overlooked in conventional obesity treatment (e.g., promoting healthy relationships with food, body appreciation, reducing weight-related stigma.) The goal of this proposal is to build and pilot test a clearly defined weight neutral intervention package that effectively targets the novel weight neutral mechanisms that are central to this therapeutic approach.